A whole body 3T MRI scanner for research

Summary / Abstract
This is an application to obtain a whole body 3 Tesla MRI scanner to support research at Vanderbilt University
Medical Center. In the past year we performed over 5,300 research scans on human subjects on 2 existing 3T
scanners, but still many less than were requested by investigators. This applications seeks to (i) add a third
scanner that will increase our capacity for research studies, especially needed given the growth of brain
imaging of neurodevelopment and neurodegeneration; (ii) provide next-generation scanner performance,
especially in the capabilities of ultra-high performance gradients for diffusion imaging; and (iii) provide
insurance against the failure of our current scanner, which has been in use for research full-time for 18 years.
Our current scanners are heavily used by over 82 active investigators with NIH funding who rely on high quality
MRI and MRS data for diverse research applications. Many of these users require advanced neuorimaging
studies that include functional and structural MRI of the brain and spine, and increasingly exploit the power of
diffusion MRI to assess white matter tracts and microstructure. We aim to enhance our current capabilities by
installing a 3 Tesla Siemens Cima.X scanner equipped with advanced Gemini gradients that can achieve 200
mT/m strength, >3 times stronger than any gradient system we currently use and capable of dramatically
increasing the types and quality of diffusion studies possible. The new gradients will provide several major
specific advantages including [1] higher gradient b values in diffusion MRI, which will allow shorter echo times,
shorter diffusion times, higher signal to noise ratio, faster acquisitions and higher spatial and angular resolution
in diffusion tractography of white matter; [2] stronger gradients will allow enable decreases in the effective
spacing between echoes in echo planar imaging, reducing geometric distortions arising from long readouts,
and allowing increased resolution in functional MRI acquisitions. In addition, the new scanner has multiple
enhancements over our current, aging scanners (e.g. larger number of receivers and coil elements, powerful
AI-aided reconstructions, and shorter exam times) that will ensure our users remain state-of-the-art for the next
several years. Our vendor selection also ensures we will be able to participate more fully in multi-site imaging
programs that are dominated by Siemens installations. In this application we highlight 16 selected Major Users,
who are PIs on 40 funded grants, all of whom are experienced users of the current 3T scanner. We also
illustrate 4 Minor Users who are representative of 23 others listed who hold 51 NIH grants that require MRI.
The projects of the Users described herein would require approximately 76% of the useable time available.
The scanner will be housed and managed within the Vanderbilt University Institute of Imaging Science, and will
be supported by a relatively large group of expert MRI scientists and staff. A comprehensive plan has been
developed for the financial support of the system as well as for its management, and the system is assured of
strong institutional support, including $3 million towards the purchase and installation.

Public health relevance
Project Narrative This is an application to obtain a 3T MRI scanner to be dedicated to research that requires state-of-the-art capabilities for imaging studies mainly of the brain and spine. The new scanner is needed (a) to increase our capacity to perform MRI studies to meet the increased needs of a large user group as well as (b) to provide enhanced imaging performance compared to current capabilities based on innovative gradient and other technology. The new scanner will have superior performance and enable a large and productive group of investigators to continue their peer-reviewed research using state-of-the-art imaging.